Infection-Dependent Vulnerabilities of Gram-negative Bacterial Pathogens

Summary
The supplement proposed will expand the capabilities of the parent grant by leveraging the
ideas already laid out in the parent grant and moving in a new direction, that of determining how
macrophages respond to compound treatment to kill bacteria. The tools we will use are well in
hand for our collaborator, Dr. Shen, and the supplement would bring Dr. Shen onto the grant as
a co-investigator and a co-mentor for Dr. Asamoto. Thus, the supplement project will take Dr.
Asamoto and the parent grant in new, exciting directions.

Public health relevance
Narrative We are using a basic biology approach grounded in host-pathogen interactions to discover new compounds that disrupt the infection process. This represents the earliest possible stage of antibiotic discovery and relies upon bacterial cell physiology, in vitro, and in vivo infection models to identify workable new research directions.